Dissecting neuron-microglia-astrocyte interaction in AD pathogenesis

PROJECT SUMMARY/ABSTRACT
The long-term goal of this project is to understand the age-related, neuron-microglia-astrocyte-specific proteome
dynamics and interaction in the brain and their deregulation in the pathogenesis of Alzheimer’s disease (AD).
Our ongoing large-scale profiling of transcriptome and proteome in bulk AD brain tissue have revealed that the
transcriptome is often not an accurate indicator of protein abundance, due to posttranscriptional events, such as
protein turnover. Genetic studies have revealed over 20 AD-related genes, many of which are associated with
specific cell types. We hypothesize that dysfunction of neuron-microglia-astrocyte interaction contributes to AD
pathogenesis, and propose to use the latest cutting edge technologies to profile cell type specific proteome, in
situ transcriptome, and proteome turnover in the three cell populations from multiple common AD-related mouse
models, to decipher molecular signaling networks in disease development, and to validate targets in human AD
cases, mouse models, and human organoid models. Three specific aims are: (i) to disentangle dynamic neuron-
microglia-astrocyte-specific proteome and interaction in AD mice by BONCAT-mediated single cell type
proteomics and spatial transcriptomics, (ii) to measure cell type-specific proteome-wide protein turnover in AD
by BONCAT pulse-chase analysis, and (iii) to study deregulation of proteome dynamics in human AD cases,
mouse models and brain organoids. Successful outcome of this project will identify novel, cell type specific
molecular components and pathways regulating cell-cell interactions during AD pathogenesis, which may
provide new therapeutic strategies for effective treatment of this devastating disorder.

Public health relevance
PROJECT NARRATIVE Alzheimer’s disease (AD) is the most common form of dementia and the sixth leading cause of death in the United States. We propose to use the latest single cell proteomics technologies to investigate the dynamics of diverse cell populations in AD models, and to decipher and validate leading targets in dynamic cell-cell interaction and AD pathogenesis using human AD cases, as well as mouse and human organoids models.